E-cigarettes Epigenetically Augment Transgenerational Abdominal Aortic Aneurysm

PROJECT SUMMARY
Abdominal aortic aneurysm (AAA) disease is a common, morbid and highly lethal disease. Importantly, there are
currently no therapeutic strategies that limit the growth of AAAs, due in part to a lack of understanding of the
mechanisms of disease and progression. In addition to advanced age, genetic predilection, and male sex, the
most crucial risk factor for AAA is a history of smoking, and at present, smoking cessation is considered the most
effective approach to decreasing AAA incidence. The recent explosion in popularity of e-cigarette “vaping” has
also raised urgent questions as to the short and long-term impacts on vascular disease risk. Published work from
our laboratory has shown that both subcutaneous infusion of the major tobacco component, nicotine, and inhaled
e-cigarette nicotine vapor, augment experimental AAA.
It has been recently appreciated that exposure to tobacco smoke, nicotine, and vaping can cause cellular
epigenetic alterations, and that in some cases these effects can be transmitted in a transgenerational fashion -
not only in animal models, but also in humans. We have new data showing that both infused nicotine and e-cig
vaping in mice augments AAA in their progeny. Additionally, with parental exposure we observed thousands of
genome alterations within the blood and tissues of both parents and offspring, including changes to both DNA
methylation and accessibility. In particular we find changes in “imprinted” genes, capable of transmitting
cardiovascular disease risk epigenetically to subsequent generations.
The outlined studies in this proposal will examine the effects of nicotine and e-cigarette vapor on the cellular
epigenetic machinery in vitro and in vivo, with a particular emphasis on heritable changes capable of augmenting
AAA. In order to verify the specific mechanisms involved, we will also seek to inhibit their impact on
transgenerational AAA risk. In Specific Aim 1, we will determine the impact of e-cigarette vapor and infused
nicotine on epigenetic patterning and imprinted gene expression in germ cells and evaluate these effects over
time in mice using multi-omic high-throughput methods. For Specific Aim 2 we will examine the effects of these
epigenetic changes on cellular signaling pathways known to be crucial for AAA pathophysiology. Finally, in
Specific Aim 3 we will seek to inhibit e-cigarette-induced DNA alterations, with a view to preventing
transgenerational AAA augmentation during a multi-generation in vivo time course. These specific aims will
provide key information regarding the potential transgenerational risk of e-cigarette use on vascular disease, and
form the basis for advancing future research and clinical translation, including potential screening for high-risk
epigenetic changes in humans.

Public health relevance
PROJECT NARRATIVE Our preliminary data show that both subcutaneous infusion of nicotine and e-cigarette nicotine vapor enhance abdominal aortic aneurysm (AAA) in preclinical animal models, augment AAA in their progeny, and induce numerous DNA alterations in parents and offspring. These results include changes in imprinted genes, capable of transmitting disease-risk transgenerationally, and have major public health implications. We propose to investigate the mechanisms behind these alterations, in order to identify the key processes.